Assessing Targeted Cannabinoid Therapeutic Potential Against HIV-1 Associated Neuronal Hyperexcitability and Neuroinflammation

PROJECT SUMMARY
Human immunodeficiency virus type 1 (HIV-1) affects over 38 million people worldwide today. While current
treatment strategies effectively suppress virus replication in peripheral tissues, the central nervous system
remains vulnerable to damage induced by viral proteins, which enter soon after initial infection and are not well
targeted by most antiretroviral therapies. It is thus critical to focus efforts on development of supplemental
intervention strategies to address persistent inflammation which presents frequently in infected individuals as
neuronal dysregulation and cognitive deficits, especially involving motivation and reward-related decision
making. Interestingly, neuronal cannabinoid type-1 receptors (CB1R) are upregulated when exposed to HIV-1
viral proteins including transactivator of transcription (Tat), one of the most neurotoxic viral proteins associated
with latent HIV-1 infection. The endogenous cannabinoid system is a promising therapeutic target as activation
reduces inflammation and restores neuronal function in models of nervous system insult. Indeed, previous
studies have shown reductions in measures of inflammation by inhibiting degradation of 2-arachidonoylglycerol
(2-AG), an endocannabinoid produced to promote cellular responses to damage in tissue or neighboring cells
and regulate activity of neurons. In exploring the protective effects of endogenous cannabinoid activity
modulation against toxicity driven by Tat, we have previously found that upregulating 2-AG through blocking its
breakdown using monoacylglycerol lipase inhibitor MJN110 is neuroprotective in models of Tat-induced neural
and cognitive dysregulation in vitro and in vivo, respectively. Given these findings, I hypothesize that inhibiting
hydrolysis of 2-AG in vivo may downregulate Tat-driven neuronal excitotoxicity during reward-related
behavior and reduce proinflammatory markers in brain tissue. However, the effects of Tat and MJN110
have not yet been characterized using in vivo imaging. Thus, the goal of this project is to determine how Tat and
MJN110 influence excitability of neurons and corresponding behavior, expression of proinflammatory cytokines
IL-6 and IL-8, as well as density of cannabinoid type-1 receptors (CB1R) on neurons and microglia in the following
two Specific Aims. Aim 1. To use in vivo one-photon microscopy during a reward-related behavioral task to
characterize activity patterns of dorsomedial prefrontal cortex neurons in the presence of Tat and/or MJN110.
Aim 2. To use immunohistochemical labeling and multiplex assays to determine whether MJN110 is able to
reduce cell-specific CB1R density or proinflammatory cytokine expression, respectively. In doing so, I will
enhance our understanding of endocannabinoid therapeutic potential against neuronal dysfunction and
inflammation which underlie complications associated with latent HIV-1 infection.

Public health relevance
PROJECT NARRATIVE The endogenous cannabinoid system acts as a major defense mechanism against inflammation and neurodegeneration in the body. This project will investigate how one therapeutic strategy may be neuroprotective in the context of latent human immunodeficiency virus-1 (HIV-1) infection, which affects over 38 million people worldwide today. These studies are essential for understanding how modulation of endocannabinoid activity influences activity of neurons during behavior, inflammatory markers in brain tissue, and neuronal cannabinoid type-1 receptor expression; and critically, how these effects may be enhanced or altered in the presence of HIV- 1 viral proteins.